Radioimmunotherapy for Multiple Myeloma

DESCRIPTION (provided by applicant): Abstract: Despite the recent introduction of new and effective novel therapies for multiple myeloma (MM), the disease remains incurable. For the 66,000 individuals in United States currently afflicted, an average survival of only four years from diagnosis is anticipated. High dose chemotherapy followed by autologous stem cell transplantation (ASCT) leads to increased rates of complete remission and prolonged periods of disease free survival, but relapse remains inevitable. There is a scientifically compelling rationale for high dose radioimmunotherapy (RIT) conditioning followed by stem cell rescue for MM. High dose RIT has demonstrated efficacy when incorporated into both autologous and allogeneic stem cell transplant conditioning regimens for acute leukemia and B-cell lymphoma. Pretargeted RIT (PRIT) represents a further refinement that can effectively circumvent the major pharmacokinetic limitations of conventional one-step RIT and dramatically improve the specificity of tumor targeting. Initial studies in murine MM xenograft models have demonstrated favorable target-to-normal organ ratios with radiolabeled anti-CD38 (OKT10) monoclonal antibody and suggest that an improved therapeutic index will result with anti-CD38 streptavidin (SA) fusion protein (OKT10[scFv]4SA) PRIT. This project is designed to identify optimal regimens for OKT10 RIT (Aim 1) and OKT10 PRIT (Aim 2); compare RIT and PRIT pharmacokinetics, biodistributions and dosimetry to identify the superior method; perform therapy studies involving murine MM tumor xenograft and SCID-hu models (Aim 3); and evaluate the safety and feasibility of myeloablative OKT10 RIT or PRIT as conditioning prior to ASCT in a Phase I clinical trial. These studies will be performed by Damian J. Green, M.D., under the guidance of an outstanding mentor (Oliver W. Press, M.D., Ph.D.) who has an established and well funded research program, extensive expertise in translational RIT research and a very successful track record of guiding junior faculty to full career independence. Mentored Career Development support will provide Dr. Green expertise in the efficient translation of preclinical discovery into clinical trials for patients with MM. The project takes advantage of the exceptional resources available at the Fred Hutchinson Cancer Research Center and at the University of Washington. Together, Drs. Green and Press have formalized a career development plan that details a combination of didactic postgraduate training in statistics, epidemiology, bioethics, drug development and immunology; hands-on clinical trial design and management experience; training to establish advanced skills in a broad array of laboratory techniques; and, a process of regularly scheduled review to ensure progress in relation to established benchmarks for productivity. Dr. Green's research project represents the logical extension of his prior translational work and an exciting opportunity for this young investigator to develop new therapies for MM. Through a process of increasing autonomy, Dr. Green will proceed to full independence with the expectation that he will be in a position to apply for competitive RO1 funding for his ongoing translational research within five years and become a leader in the field of RIT, MM and stem cell transplantation within a decade.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project Narrative: Patients diagnosed with multiple myeloma, the second most common blood cancer in the United States, live an average of only four years after diagnoses and cannot be cured with standard treatments. Stem cell or bone marrow transplant may prolong survival, but the disease almost always returns. This project is designed to develop a new approach, already proven effective for patients with leukemia and lymphoma, that directly targets multiple myeloma cells with small radioactive particles to selectively destroy them. Project Narrative: Patients diagnosed with multiple myeloma, the second most common blood cancer in the United States, live an average of only four years after diagnoses and cannot be cured with standard treatments. Stem cell or bone marrow transplant may prolong survival, but the disease almost always returns. This project is designed to develop a new approach, already proven effective for patients with leukemia and lymphoma, that directly targets multiple myeloma cells with small radioactive particles to selectively destroy them. __SpecificAimsTextDelimiter__ Specific Aims Aim 1: To characterize the pharmacokinetics, biodistribution and dosimetry of radiolabeled DOTA conjugated anti-human hCD38 antibody (OKT10-DOTA) in a mouse xenograft model bearing human multiple myeloma tumor cells. Hypotheses being tested: 1). Anti-CD38 antibody radiolabeled with 111Indium will demonstrate favorable blood clearance kinetics. 2). Anti-CD38 antibody radiolabeled with 111Indium will result in biodistributions of radioactivity demonstrating selective targeting of multiple myeloma cells when compared with radiolabeled nonbinding IgG matched control antibody (BHV-1). 3). All-trans retinoic acid (ATRA) will act as a potent inducer of CD38 receptor expression and will result in biodistributions demonstrating superior target-to-nontarget ratios of radiation delivery. 4) Dosimetry analysis will demonstrate favorable target-to- normal organ ratios. Aim 2: To characterize the pharmacokinetics, biodistribution and dosimetry of radio-biotin pretargeted with an anti-CD38 OKT10 (scFv)4-streptavidin fusion protein (OKT10-FP) in a mouse xenograft model bearing human multiple myeloma tumor cells. Hypotheses being tested: 1). OKT10-FP will specifically target radiolabeled DOTA-biotin to malignant plasma cells. 2) A synthetic "clearing agent" will deplete >90% of circulating OKT10- FP from the bloodstream within 30 minutes of administration. 3). Pretargeted radioimmunotherapy (PRIT) will produce superior biodistributions of radioactivity compared with conventional one step radioimmunotherapy (RIT), as assessed by the ability to deliver higher radiation doses to tumor cells while maintaining safe radiation doses to critical non-target organs. Aim 3: To evaluate the therapeutic efficacy of 90Y radiolabeled DOTA-biotin targeted to (a) mouse myeloma xenografts; and (b) malignant plasma cells in SCID-hu mouse myeloma models using OKT10-FP. Hypotheses being tested: 1). Anti-CD38 antibody radiolabeled with 90Yttrium will demonstrate a dose dependant therapeutic response in tumor cells. 2). ATRA will further enhance the therapeutic index of CD38 targeted RIT. 3) The proteasome inhibitor, bortezomib, will increase the therapeutic benefit of anti-CD38 RIT and will be associated with tolerable toxicity. 4). A detailed characterization of the biological behavior of myeloma tumor cells will be possible in each murine model system using bioluminescent imaging in concert with direct quantitation of radioactivity in excised tissues. 5) The efficacy of RIT targeting CD38 antigen will be demonstrable in both tumor xenograft and SCID-hu mouse models. Aim 4: To initiate a Phase I clinical trial evaluating myeloablative autologous stem cell transplantation using (OKT10-FP) to pretarget 90Y-DOTA biotin to myeloma cells. Hypothesis being tested: 1) OKT10-FP pretargeting will be feasible and safe in this population. 2). OKT-10 FP pretargeting will result in favorable target to normal organ ratios of absorbed radioactivity. 3). OKT-10 FP pretargeting will be an effective method of myeloablative conditioning. 4). Autologous stem cell transplantation employing OKT-FP pretargeting as conditioning will result in prolonged periods of disease free survival and overall survival when compared to historical controls receiving standard melphalan conditioning regimens. 5.) Adjunctive radiosensitizing therapy with novel anti-myeloma agents will improve the efficacy of the radioimmunotherapy.